Methods to modulate GI inflammatory and infectious diseases

Infectious diseases are significant healthcare problems. As pathogenesis of the disease are triggered by
bacteria and virus, commonly used medications are small molecule drugs. However, bacteria and virus often
mutate and makes it challenging to develop a standard of care medications. Hence, vaccines, which are
immunotherapy regimens to inject live or attenuated antigens to develop immunity against the pathogens are
used for prophylactic and therapeutic applications. However, vaccines are less effective against gastrointestinal
(GI) infectious diseases as generating mucosal immunity requires extensive activation of GI immune cells. In this
study, we aim to develop a vaccine adjuvant system which can be delivered by oral route, and selectively
activate GI immune cells to elicit strong mucosal immunity which will be pursued by following specific aims.
Aim1. We will identify a novel small molecule which can specifically activate GI immune cells without
triggering chronic GI inflammation. To do so, we will develop in vitro assays which allow high throughput screen
(HTS) of drug libraries. Using HTS assay, we will discover a hit compound that induces pro-inflammatory
cytokine, TNF-alpha from primary dendritic cells but does not induce TNF-alpha from GI endothelial cell line
Caco-2. Then, we will develop a nanoparticle drug delivery carrier suitable for oral delivery. We will develop
polymeric nanoparticles that can provide protection of the hit compound from degradation in the GI tract, and
enhance uptake by GI immune cells in the intestine, all of which are important for inducing mucosal immunity in
GI tract.
Aim 2. Hit compound encapsulating nanoparticles (refer to as Nano-Adjuvant) will be examined for in vivo
safety and efficacy in rodent animal models. Biodistribution and pharmacokinetic profile of nanoparticles will be
measured using IVIS fluorescence imaging and LC/MS analysis and histological analysis of organs will be
performed to investigate the potential toxicity of Nano-adjuvant. Next, we will examine the immunostimulatory
efficacy of Nano-adjuvant by measuring the T cell and B cell activation (small intestinal cells, mesenteric lymph
nodes) using flow cytometry, and mucosal immunity (Intestinal wash IgA, fecal IgA).
In this proposal, we will focus our efforts to examine whether oral nanoparticulate delivery of small molecule
can elicit strong mucosal immunity without inducing GI inflammation by HTS screening and in vivo safety and
efficacy validations. Long term goal of the project is to develop a universal oral immunostimulatory adjuvant
which can be used as a vaccine when combined with antigen sources, or as a complementary immunotherapy
agent when combined with anti-biotics or anti-virus drugs to treat GI infectious diseases.